Substance Use Among American Indian Youth: Epidemiology and Etiology

Project Summary
This ongoing integrated epidemiologic and etiologic research study (Our Youth, Our Future) is the only
source of nationally-representative substance use data for reservation-area American Indian (AI) adolescents,
a population that is at-risk and experiences large health disparities. Substance use rates among AI
adolescents have been greater than national rates for decades, and our current findings point to complex
changes since the onset of COVID-19.
Each year, 3,000 or more 6th - 12th grade reservation-area AI students will be surveyed to provide
nationally-representative rates of substance use for this population. In collaboration with Monitoring the Future
researchers, these rates will be compared with national rates to identify areas of special concern for
reservation-area AI youth. In addition, age, period, and cohort effects will be distinguished by combining our
past data with data gathered in the upcoming cycle, emphasizing substance use before, during, and after the
onset of COVID-19, to identify changes in substance use and related constructs due to historical (e.g., COVID-
19), regulatory, and normative factors. Finally, we will examine heterogeneity in SU disparities among
reservation-area American Indian youth across intersections of sociodemographic identities and contextual
variables using intersectional multilevel analysis of individual heterogeneity and discriminatory accuracy.
Collecting data from multiple reservations across the country yields a unique opportunity to conduct the
first systematic assessment of Social Determinants of Health (SDOH) impacts on substance use and related
constructs for this population. A wide range of SDOH factors specific to reservation communities will be
compiled in order to identify how SDOH factors either contribute to or shield against use, providing a
comprehensive perspective on the interplay of vulnerabilities and strengths within AI communities.
Building etiologic evidence for substance use prevention efforts is also a key part of this project.
Although AI youth are influenced by broader society, unique individual, cultural, and contextual factors
influence substance use. An Ecosystemic Resilience Framework (ERF) will guide examination of the
ecosystemic resilience processes involved in the relationships of adversity to substance use and its
comorbidities in reservation-area AI youth, with particular emphasis on unique cultural and community factors.
This will provide actionable insights for prevention efforts. Additionally, we will expand the ERF to incorporate
an intersectional analytic approach to examine how ecosystemic risk and resilience processes impact SU
among AI youth occupying different socio-demographic intersections and social contexts.
Project findings will be disseminated to key stakeholders, with special emphasis on tribal and non-tribal
entities involved in policy and resource-related decisions that affect AI youth substance use.

Public health relevance
Project Narrative Substance use rates among American Indian adolescents have been greater than national rates for decades, and our current findings point to complex changes in SU since the onset of COVID- 19. This proposed study will continue to monitor rates of use for reservation American Indian adolescents and compare these rates to national rates, in addition to estimating relationships between substance use and measures of strength and resilience especially pertinent to this population and to Social Determinants of Health. The findings from this study will be disseminated to key stakeholders including participating schools and local and national Native groups and organizations, and will inform prevention, intervention, and policy efforts designed to reduce substance use among this population.